ACTG 245 ANTIRETROVIRAL THERAPY IN CHILDREN WITH ADVANCED HIV

To compare antiviral activity of combination therapies as measured by reduction of plasma IDC p24 antigen at 48 weeks, to compare safety and toxicities of combination therapies and to evaluate steady-state zidovudine, didanosine and Nevirapine.